Nanopores for Processing Proteins

Project Summary
The ultimate goal in the field of proteomics is single-molecule, high-accuracy, de novo protein sequencing.
Unfortunately, current technologies used to characterize and identify proteins are costly, and lack the sensitivity,
dynamic range, throughput, scale, and accuracy needed to meet the ever-expanding needs within this field.
During this Phase I SBIR project, Electronic BioSciences, Inc. (EBS) aims to develop a nanopore reader, along
with the associate methodology, capable of direct, single-molecule protein sequencing. A sensor capable of
examining single proteins will not only provide detailed information regarding the individual protein themselves,
it will also enable proteome-wide profiling and protein characterization, biomarker(s) discovery, and the
associated assessments of disease state progression or remission. The prototype sensor developed here will
be a high-accuracy nanopore-based reader capable of label-free sequence characterization that provides high-
quality data without sequence-context convolution. This development will be the first of its kind, ideally suited to
assessing and sequencing any given protein, regardless of length and structure. Additionally, the sensitivity of
the proposed reader will enable the ability to detect and identify specific post translational modifications, which
is critical to understanding and assessing the extensive variation within the proteome.

Public health relevance
Project Narrative This program will yield the first-ever method for direct, high-throughput, single-molecule, de novo, protein sequencing. A protein sequencing technology that can accurately distinguish all 20 natural amino acids, and potentially the post translational modifications thereof, will greatly advance proteomics research and propel the field into protein-targeted diagnostics, prognostics, and therapeutic interventions, where methods have lagged relative to analogous nucleic acid-based technologies. Novel protein analysis methods are needed to assess the breadth of proteome variation, which is not fully accessible though nucleic acid analyses.